IGF::OT::IGF OTHER FUNCTIONS. Scientific Support Services for the National Cancer Institute, Division of Cancer Control and Population Sciences (DCCPS).

The objective of this requirement is to support the scientific, technical, and logistical activities in DCCPS, which collectively improve public health and the understanding of cancer risk, incidence, and outcomes. Results from these efforts are used to convey evidence-based cancer control information, research tools and resources, trainings, and scientific findings to a wide range of constituents including the extramural research and scientific communities; health practitioners; NIH and U.S. Department of Health and Human Services leaders; scientific advisory boards; consumer liaisons; Congress; partner organizations within and outside government; cancer advocates; cancer patients; and the general public.